31st Fungal Genetics Conference

The 31st Fungal Genetics Conference will be held at the Asilomar Conference Center, March 15 -20, 2022. This
biennial conference is one of the premiere international meetings for fungal biologists. Approximately 900 US
and international scientists and students are expected to attend in-person, with virtual attendance a new
opportunity available for the first time in 2022. Goals of this biennial meeting are 1) to promote the dissemination
of the latest research on all aspects of the biology of fungi with a focus on filamentous fungi and 2) to promote
communication and collaboration between Medical Mycologists and those working with other fungal systems.
This has led to recruitment of mycologists to Medical Mycology. Understanding the biology of fungi and their host
interactions is critical to, and has been successful in, the development of new antifungal therapeutics. The 31st
FGC will have four plenary sessions, four sets of concurrent sessions, and three poster sessions. The plenary
topics are: Cell Biology and Morphology, Cross-Species Interactions, Evolution and Development, and Signaling
and Metabolism. The 28 concurrent session topics are: Human fungal pathogens, RNA and RNAi biology,
Symbionts and endophytes, Morphological transitions, Extreme environments, Interactions with prokaryotes and
viruses, Circadian rhythms and photobiology, Plant Pathogens, Secondary metabolism and production of useful
metabolites, Stress, Chromatin, heterochromatin, and epigenetics, The mitotic spore: development, dormancy
and germination, Lipid metabolism and signaling, Natural and experimental diversity, evolution and populations,
Interactions with other non-human/plant eukaryotic species, Natural and applied bioconversion (bioremediation,
lignin degradation, biofuels), Mycobiomes and their implications, Mating and sexual development, Molecular
basis of biotrophy, Speciation, diversity and evolution, Small molecules in communication, Fungal determinants
of host response, Fungi in a changing world - climate change, pandemics, Fungicides and antifungals, Coolest
tools for fungal biology, From genome to pangenome, Fungal recognition (self and non-self), Systems biology
and biomaterials. Four of the twenty plenary session talks are on medically important fungi and 7 of the 28
concurrent sessions have a significant focus on medical mycology. Other concurrent sessions will include talks
on medically relevant fungi. The FGC places a strong emphasis on the participation of young scientists and
students, particularly those from underrepresented groups. Many have their first opportunity to present their
research at a major international conference. Funds are requested to help defray travel and participation costs
of students, postdoctoral researchers and some young scientists, and will be distributed on a need basis.

Public health relevance
This conference brings together fungal biologists working on most major fungal systems and promotes communication and collaboration between those working on fungi related to human health including Medical mycologists, working on fungi that cause diseases of people and those working on food security as well as others working on plant pathogens, saprobes and symbiotic fungi. This interaction allows students interested in mycology to find and pursue opportunities for research careers in Infectious Diseases and other areas towards reducing the impact of fungi on human health. Fungi also serve as important model systems to understand basic processes in cells that when altered result in diseases of people based on the presence in fungi of many genes and metabolic and regulatory pathways relevant to those altered in people impacted by these diseases.